Control of Drosophila intestinal homeostasis by RhoGap15b

Project Summary/Abstract
The overall goal of this proposal is to understand how organisms as diverse as humans and the fruit flies use
the same molecules to decide when and where cells will divide, especially when they are needed to repair
damaged tissues. The specific focus of this application is a protein that is highly conserved from insects to
humans, and appears to act specifically in the adult gut to support stem cell renewal of this tissue over the
organism's lifespan. Despite its apparent importance to gut homeostasis, the protein has not been the subject
of sustained study. Our preliminary data indicate that acts as a signaling hub that receives inputs from
phospholipids and in turn delivers regulatory outputs onto two highly conserved pathways broadly involved in
human health and disease. We are very excited to leverage the strength of our data to understand how
this protein coordinates these various roles within intestinal stems cells in Drosophila. Our own cells have
a version of this protein, so we believe that our work will shed light on mechanisms that support our stem cells
too.

Public health relevance
Project Narrative Stem cells play critical roles in maintaining the lifespan of key tissue and healthspan of organisms. Here we will study a protein that plays a critical role in intestinal stem cells, and hope to gain insight into how it maintains gut function in aging adults. Its functional properties suggest it may acts a hub to coordinate the function of other critical pathways.